Core A - Administration

CORE A SUMMARY
Administrative Core. The overall goal of this Program Project is to elucidate the biological mechanisms of
ectopic calcification and its roles in the onset and etiology of diseases of aging, with particular focus on age-
related macular degeneration (AMD) and Alzheimer’s disease (AD). The major components of ectopic
calcifications are proteins, lipids and mineralized calcium phosphate, especially hydroxyapatite (HAP) and
whitlockite (WHT), but the roles of these components in the calcification process and disease progression are
not known. Four Projects and one technical Core will collaborate to gain a comprehensive mechanistic view of
ectopic calcification in age-related pathologies. Achieving this goal requires an integrated multidisciplinary
approach that combines multi-scale structural biology, biochemistry, cell biology and animal physiology, guided
by experts in these specific areas. The principal role of the Administrative Core is to ensure the success of the
Program as an integrated multidisciplinary and multi-scale investigative effort, and generate a comprehensive
view of calcification in diseases of aging that could not achieved by individual laboratories working alone. This
is essential for gaining comprehensive biomedical insights. To support this goal, the Core will facilitate
interactions among the investigators and provide a strong administrative structure.